Understanding the Fate of Metaplastic Tuft Cells in the Progression of Pancreatic Cancer

Project Summary/Abstract
Pancreatic ductal adenocarcinoma (PDA) is predicted to become the second leading cause of cancer-related
death in 2025 and has a 5-year survival rate of only 10%. The progression of pancreatic disease is partly driven
by the transdifferentiation of acinar cells into metaplastic ducts in the pancreas. Metaplastic tuft cells (MTCs) are
a specialized subset of the metaplastic epithelium that has been previously described as cancer stem cells in
pancreatic cancer. Also known as solitary chemosensory cells, tuft cells were first discovered in rodent luminal
surfaces, including the nose, stomach, intestine, and bladder, more than 60 years ago. They are characterized
by the “tuft” of microvilli reaching into the lumen and, only recently, have studies started to determine the role of
normal tuft cells in different organs. These studies determined that tuft cells have unique functions depending
on the organ in which they reside. Tuft cells are found in several various organs during development; however,
studies have shown that tuft cells are not present in a normal pancreas. MTCs are only present in the pancreas
in PanINs during PDA progression in both humans and mice.
Furthermore, the population of MTCs in the pancreas disappears as PDA progresses into invasive carcinoma
when using canonical markers of tuft cells. We know little about the role of MTCs in the pancreas, but prior
studies have suggested their role as a progenitor cell during PDA. However, these studies do not exclusively
mark MTCs during their genesis in a progressive model of PDA due to a lack of mouse models and the complexity
of culturing them ex vivo. We have generated a unique mouse model to drive lineage tracing of MTCs during
PDA and a novel culture method to propagate MTCs ex vivo. I have preliminary data to suggest that MTCs are
not disappearing as PDA progresses but transdifferentiate into neuroendocrine cells as PanIns dedifferentiate
into invasive carcinoma. Our collaborations with Dr. Rosalie Sears have led to a publication investigating NECs,
which are a highly aggressive cell type in PDA. In this publication, we establish that MYC is a driving factor of
NEC development. We believe that MYC is a driving factor in the transdifferentiation of MTCs into NECs. It is
also known that both MTCs and NECs derive from the acinar cells. This transdifferentiation into MTCs and NECs
occurs during metaplastic development. Our central hypothesis is that Myc is a driving factor in MTCs
transdifferentiating into NECs. Through our unique lineage trace mouse model, we can trace MTCs into PDA
development when we overexpress or knockdown Myc in MTCs specifically and determine its role in Tuft to
Neuroendocrine Transdifferentiation (TNT).

Public health relevance
Project Narrative: Pancreatic cancer is almost universally fatal. Metaplastic tuft cells (MTCs) are hypothesized to be tumor initiating cells in pancreatic cancer. In this proposal, I will use novel genetic models of pancreatic cancer to determine the fate of MTCs and the role of c-Myc in MTC transdifferentiation and metastasis initiation.